Measuring neurodevelopmental effects of polygenic risk for Alzheimer's disease via longitudinal study of brain and cognitive variables in periadolescent children

Project Summary/Abstract
Alzheimer’s disease (AD) is a devastating, progressive neurological disorder that selectively degrades the
cognition of many older adults — 6.1 million are living with AD in the US today and the estimated prevalence
by 2050 is 12.7 million. Patients diagnosed with AD often live 8-10 years with the disease, but declines in
memory and other cognitive abilities mean that patients face loss of independence and high costs of care
(estimated to be $186 billion in 2018). Management of AD risk with targeted interventions is a needed part of
our public health response, and genetic factors affecting AD risk will be essential to those efforts because they
are present throughout the lifespan. Critically, it is possible that genetic AD risk factors may bias brain and
cognitive development to increase vulnerability to AD later in life. A putative neurodevelopmental influence of
genes on AD vulnerability would be consistent with 1) the predictive power of early cognitive ability for later AD
risk, and 2) wide variability in how AD pathology (e.g., Aβ deposition) relates to AD symptomology (e.g.,
memory loss). Here, we hypothesize that genomic AD risk alters neurodevelopment of the brain systems
most affected by AD in ways that increase AD vulnerability. If true, then properties of AD-affected brain
structures and brain networks such as the hippocampus and functionally-coupled memory networks will vary
with genetic AD risk even during youth. Measuring how genetic factors affect brain development will elucidate
lifelong trends for AD risk while highlighting new opportunities for early intervention.
The project lead is a new, early-stage investigator with a background in the cognitive neuroscience of memory
and expertise in methods including neuroimaging and neuropsychology. In this study the investigators will
apply these methods to the study of early polygenic effects on neurodevelopment that may affect the risk of
late-onset neurodegenerative diseases including AD. Key preliminary data from large developmental datasets
have provided important early support for this hypothesis, and the current proposal describes a new, tightly
focused project designed to fill critical gaps in our existing knowledge. The Specific Aims are: 1) Measure
effects of AD-related genes on developmental differences in AD-vulnerable brain regions; 2) Quantify how
genes affect development of functional brain networks that are later vulnerable to AD; 3) Test developmental
differences in AD-vulnerable cognitive abilities attributable to AD-related genes. For these Aims, the research
team will develop a new dataset from a large sample (N=270) of healthy youths aged 9, 11, or 13 years by
combining neuroimaging (brain structure/function), neuropsychological tests (cognition), and genomic assays
(AD-related genes) in a longitudinal design. These data will improve the field’s understanding of the pressing
clinical problem of AD from a developmental risk perspective. While addressing AD by studying children
appears counterintuitive, this approach may be a crucial step toward addressing a looming public health
catastrophe: some of today’s children are primed to become tomorrow’s dementia patients.

Public health relevance
Project Narrative Public health agencies face a serious challenge in the growing prevalence of older adults with Alzheimer’s disease (AD), and vital insights about AD risk may be found in how genes drive childhood brain development. In this research project, the applicants will test the hypothesis that AD risk genes alter neurodevelopment of the brain systems most affected by AD in ways that increase AD vulnerability. By measuring brain and cognitive variables longitudinally in healthy children who have different genetic risk profiles for late-onset AD, this research project could identify opportunities for early intervention to reduce the risk of developing late- onset AD and thus promote the key NIH goal of "understanding the complex interaction between genes and environment as it relates to Alzheimer’s risk."